Gut Serotonergic Signaling in Traumatic Brain Injury

Project Summary/Abstract: Traumatic brain injury (TBI) represents a signiﬁcant public health concern in the
United States, with an estimated annual economic burden of $56.3 billion and a subsequent risk of
neuropsychiatric and neurodegenerative diseases. Emerging research has highlighted the signiﬁcant
communication along the brain-gut axis as a driver of increased neuroinﬂammation. Furthermore, both
preclinical and clinical studies have identiﬁed serotonin (5-HT) as a key player in the pathogenesis of TBI, with
existing literature primarily focusing on brain serotonergic signaling. In our proposal, we aim to address this
gap by investigating the role of serotonergic signaling in the gut. Enteroendocrine cells (EECs) are specialized
cells that line the intestinal epithelium forming the body’s largest endocrine system and are responsible for
producing 90% of the body’s serotonin. Our lab recently discovered a signiﬁcant reduction in EEC expression
and differentiation, as well as a decrease in serotonin synthesis following TBI. Additionally, we have
demonstrated that TBI triggers the gut’s inflammatory immunoendocrine axis, as observed by an increase in
inflammatory macrophages and decreased serotonin production, indicating a potential interaction between
inﬁltrating macrophages and serotonin production by EECs. Alterations in the gut microbiome further modulate
serotonin metabolism, suggesting a complex interplay between microbiota and intestinal serotonin. This
proposal will investigate the mechanisms by which serotonin interacts with the various macrophage/microglial
populations and how these interactions modulate the brain’s inflammatory response. Serotonin signaling will be
restored through two novel approaches: (1) pharmacologically, by supplementing the prokinetic/laxative
prucalopride, known to activate serotonin receptors (5HT4 receptor agonist), and (2) genetically, by generating
mice that selectively overexpress EECs and serotonin in the gut epithelium. Behavioral outcomes, including
spatial learning and memory, risk-taking/anxiety, and depressive-like behaviors, will be assessed at acute and
chronic time points. We hypothesize that TBI induces EEC dysfunction and decreases serotonin production,
which ultimately worsens brain neuroinflammation by inducing macrophage polarization into a pro-
inflammatory state and modulating vagus nerve function. The overarching goal is to enhance serotonin
production and suppress the proinflammatory response, with the aim of improving neurocognitive outcomes
(Aims 1&2). Furthermore, we aim to utilize novel treatment strategies, such as non-invasive transcutaneous
auricular vagus nerve stimulation (taVNS), to improve gut function and reverse brain neuroinflammation post-
TBI (Aim 3). Collectively, the proposed studies will identify a key role for serotonin as a paracrine/endocrine
hormone mediating the inflammatory response along the brain-gut-brain axis through its effects on
macrophages, microbiota and vagus nerve function, with the potential for novel therapeutic interventions for
TBI patients.

Public health relevance
Project Narrative: Traumatic brain injury (TBI) is a devastating disease that leads to chronic neurodegenerative sequalae, with approximately 190 Americans dying each day from TBI-related injuries. The gut has emerged as a crucial player in mediating brain injury via the gut-brain axis by secreting 90% of the body’s serotonin. This proposal aims to investigate the role of intestinal serotonin signaling in influencing neurocognitive and psychological outcomes following TBI, and to develop pharmacologic therapies for TBI patients.